RACIAL HARASSMENT AND DISCRIMINATION--CAUSES AND EFFECTS

This project examines factors affecting the incidence of racial harassment and discrimination, and the multiple consequences of the stress of racial harassment and discrimination. Research suggests that Hispanic employees who experienced racial discrimination, and their White coworkers who were aware of it, showed higher levels Of stress. Further, African-Americans and Hispanics who reported racial discrimination exhibited poorer health conditions and psychological well-being. The project tests a model which distinguishes between racial harassment (i.e., unfavorable race-related comments or gestures) and racial discrimination (i.e., unfair employment- related treatment of employees of one race over another). Further, the model predicts that a negative organizational climate for racial/ethnic minorities affects the occurrence of racial harassment and discrimination, and that those who are racially harassed or discriminated against experience increased stress, and negative job-related (e.g., job satisfaction, organizational withdrawal), health (e.g., health conditions, health satisfaction), and psychological outcomes (e.g., self-esteem, satisfaction with life). In addition, the project explores how the stress of racial harassment and discrimination differentially affects those who experience such events, and their coworkers who are aware of, or witness such events. Finally, it also examines how employees of different racial/ethnic backgrounds are differentially affected by the stress of experiencing or being aware of racial harassment and discrimination. Participants are 1500 graduate students at an ethnically diverse (approximately 50% Hispanic), South-Western, university. Participants will complete a survey which assesses their perceptions of university climate, experiences of racial harassment and discrimination and job-related, health and psychological outcomes. Data will be analyzed by the LISREL VIII approach to structural equations modeling. Results can be used to design interventions and will contribute to the understanding of the role of culture in responses to the stress of racial harassment and discrimination.